PHASE I, OPEN LABEL, ESCALATING DOSETRIAL OF SDZ 969 IN MYELODYSPLASTIC PATIENTS

Evaluate the effects of rhlL-6 related to hepatocyte, bone metabolism and other hematopoietic and non-hematopoietic cells through an open label, multi-center non-randomized trial.